INCIDENCE OF PSEUDOPAPILLEDEMA IN PROLACTINOMA PATIENTS

Hypothesis: A subpopulation of prolactinoma patients may have a syndrome of congential malformations consisting of pseudopapilledema and anomalous arterial supply of the pituitary by-passing hypothalamic dopamine inhibition. Exclusion of pituitary tissue from dopamine regulation may predispose a patient to prolactinoma formation. The current proposal proposes to investigate the incidence of pseudopapilledema in prolactinoma patients.